Mechanisms of Immunosurveillance for Lung Cancer-the Role of CD8+ T Cells in Tumor Tolerance Induction

Lung cancer remains the major cancer-related cause of death in the Western World and intense
efforts are directed toward the development of immunotherapy for the treatment of this disease.
While immunotherapy targeting cytotoxic T (CD8+ T) lymphocytes has been successful in several
malignancies, such as melanoma and prostate cancer, it has demonstrated only limited success
in lung cancer. Based on our laboratory’s work in lung transplantation, where we have
demonstrated a tolerogenic role for alloreactive CD8+ T cells, we have now generated preclinical
animal data which demonstrates that, unlike the case for other malignancies, the presence of
conventional CD8+ T cells can accelerate the growth of both transplantable as well as
carcinogen-induced lung cancer in a murine model. In this Merit Award application we propose
a series of coordinated but non-overlapping specific aims to delineate the tolerogenic role of CD8+
T cells in lung cancer, identify mechanisms responsible for CD8+ T cell-mediated downregulation
of the immune response, as well as define the interaction of CD8+ T cells with natural killer cells.
This proposal will extend our understanding of lung cancer-specific immunoregulation and
generate novel preclinical data that can be utilized for rational design of lung cancer- specific
novel therapeutic approaches for Veterans and the general population.

Public health relevance
Lung cancer remains the number one cause of death in the United States, disproportionately affecting the military and Veteran population. Little information is available regarding the role of the immune system in controlling the growth of lung cancer. Here we investigate the surprising finding that CD8+ T cells, which can eliminate many types of malignancies, can accelerate the growth of lung cancer. This application focuses on understanding such mechanisms of tolerance in an effort to improve lung cancer-specific immunotherapy; and possible repurposing of existing drugs for lung cancer immunotherapy based on fundamental understanding of lung cancer biology and immunoregulation.